Novel Ultrasound Based Viscoelasticity Imaging Tool to Reduce Invasive Breast Lesion Biopsy Rate

Project Summary/Abstract
Rush River Research Corporation, in collaboration with the Mayo Clinic, proposes to develop a novel, user-
friendly, non-invasive diagnostic tool to measure viscoelasticity of breast tissue which can be used to
characterize breast lesions as benign or malignant. Breast cancer is the second most common malignancy
among women in the United States and a leading cause of cancer-related deaths in females. The diagnostic
journey typically involves multiple screenings and follow-on diagnostics techniques. Following positive results
from these less invasive diagnostics, a biopsy is typically performed. However, most biopsies performed on
women who screened positive for breast cancer using typical screening methods are found to be benign. This
results in a large physical, emotional, and economic burden experienced by women who do not have cancer.
Additionally, the cost of potentially unwarranted benign biopsies is more than $2 billion annually in the United
States. The proposed new tool to measure viscoelasticity of tissue will provide quantitative feedback on who
should receive a biopsy as well as a 2D colormap image of the tumor. The novel tool uses existing ultrasound
machines and ultrasound heads and can be done at the same appointment as a diagnostic ultrasound using
the same machine. A mechanical attachment is required to provide an automated, force-controlled, dynamic,
axial compression and will be developed and tested using phantoms in this project. This technology will
provide physicians with a better tool for decision-making and help women avoid unnecessary biopsies.

Public health relevance
Project Narrative Research has shown that most biopsies performed on women who screened positive for breast cancer using typical screening methods are found to be benign. Receiving a false-positive result from an abnormal screening mammogram adds potential psychological distress, additional health care visits, diagnostic tests, physical discomfort, and associated costs. Successful completion of this research will lead to a new non- invasive tool to reduce the number of women requiring biopsies.